SF2UF: The Bridges to the Baccalaureate partnership between Santa Fe College and the University of Florida

Project Summary/Abstract
Santa Fe College (SF) and the University of Florida (UF) seek to continue the SF2UF program,
a partnership designed to increase the number of underrepresented (UR) students who transfer
from SF to UF, graduate with baccalaureate degrees, and continue to careers in biomedical and
behavioral science-related disciplines. For the purposes of the SF2UF project, UR students are
those who meet at least one of the following criteria:1) individuals from racial and ethnic groups
that are underrepresented in health-related sciences (Blacks or African Americans, Hispanics or
Latinos, American Indians or Alaska Natives, Native Hawaiians and other Pacific Islanders), 2)
individuals with disabilities, and 3) individuals from disadvantaged backgrounds (per NIH NOT-
OD-20-031). The SF2UF program design is based on three foundational principles: 1) the first
two years of college are the most critical for recruitment and retention of students in the
sciences; 2) early and consistent participation in high-quality mentored research increases
retention and academic performance, especially among UR students; and 3) addressing mental
health and wellness with students should be an essential component of a training program for
UR undergraduate transfer students. The program has five measurable specific aims as
performance targets: 1) increase by 25% the number of freshman students at SF enrolled in the
program-associated courses who are considering a career as a research scientist, 2) recruit 29
trainees into the SF2UF program over five years, 2) achieve 100% of the trainees successfully
transferring to UF or another four-year institution, 3) retain at least 90% of the trainees for the
full three-year training period, 4) graduate at least 90% of the trainees with a B.S. degree within
four years of joining the program, and 5) achieve at least 75% of the trainees continuing to a
post-baccalaureate degree programs — including at least 60% continuing to a Ph.D. degree
program — within two years of earning the BS degree. The SF2UF program aims to achieve
these targets with novel educational programs at SF, and an integrated research mentoring and
career development experience at SF and UF designed to prepare the trainees for matriculation
to a competitive Ph.D. program.

Public health relevance
Project Narrative Diverse perspectives in biomedical and behavioral research lead to greater innovation and greater recognition of issues that continue to threaten the health, well-being, and inclusion of underrepresented communities. Consequently, increasing the diversity of biomedical and behavioral research scientists increases our potential to address the most urgent public health challenges, and is critical to the full realization of our national research goals. The proposed SF2UF program would integrate activities between a two-year college and a major research university to expand the pool of traditionally underrepresented (UR) students who are considering a career as a research scientist, recruit UF trainees from this pool and place them in mentored research environments with experienced faculty mentors at the research university, and support these trainees through to their graduation with a B.S. degree and continuation to a successful career in biomedical and behavioral research.